Fecal Microbiota Transplant for C. difficile Infection in Solid Organ Transplant Recipients

Abstract
Clostridium difficile is the most frequent bacterial cause of antibiotic-associated diarrhea. Solid
organ transplant recipients have a higher rate of C. difficile infection (CDI), and greater risk for
adverse consequences because of immunosuppression, frequent antibiotic use and medical
procedures all of which disrupt the normal gut microbiota. Dysbiosis of the gut microbiota
predisposes to CDI which, despite treatment can recur in 30% of patients. A novel way to
prevent CDI recurrence is by instilling feces from a healthy individual into the intestine of the
CDI patient, thereby restoring balance in the gut microbiota. However, it is unknown whether or
not fecal microbiota transplantation (FMT) is an efficacious choice for CDI recurrence prevention
in SOT recipients. We propose a randomized, double-blind double-dummy placebo-controlled
trial at five sites comparing FMT with oral vancomycin for 158 SOT recipients with at least a first
but no more than 3 recurrences of CDI. We will collect fecal and blood samples from subjects
prior to and after FMT and collect data on recurrence, CDI-related quality of life, microbiota
composition and function. The trial's primary endpoint is recurrent CDI in the 60-day time frame
following completion of treatment. Secondary outcomes are safety and gut microbiota
characteristics. Each subject will contribute 6 stool samples, 3 blood samples and will have 6
clinic visits. Total duration of follow-up will be 24 weeks per subject. The FMT will be
administered via enema using frozen stool from universal donors. By following patients for 6
months, we will determine whether FMT successfully and safely reduces recurrence of CDI and
improves other outcomes in SOT recipients with CDI.

Public health relevance
Narrative Solid organ transplantation (SOT) is an important treatment for end stage organ failure of many kinds. However, due to immunosuppression, frequent antibiotic use and medical procedures all of which cause disruption of the normal gut bacterial community, SOT is associated with a high rate of Clostridium difficile infection (CDI) and recurrent CDI. Fecal microbiota transplantation (FMT) may reduce recurrence by replenishing normal gut bacterial communities. We propose a clinical trial to determine the effect of FMT on CDI recurrence in SOT recipients with C. difficile infection compared with usual care.